Metabolic Changes: Connecting temperature sensing neurons to sympathetic adipose tissue stimulation

Dynamic changes in leptin levels in response to fasting are well known, and these responses are blunted in metabolic diseases such as obesity and diabetes. Leptin acts via leptin receptors in the brain to modulate many neuronal functions, including neuronal activity, neurogenesis, axonal growth, and synaptic strength. An increasing number of recent studies also highlight a role of leptin levels for the onset or progression of brain disorders like neurodegenerative disease (e.g. Alzheimer’s disease), learning and memory deficits, substance abuse, mental illness (e.g. depression) and neuropathic pain. The precise regulation of the dynamic changes in circulating leptin, which is also considered an interoceptive signal, are at the core to maintain normal neuronal function in both the central and peripheral nervous systems.

Previous work from others has shown that sympathetic activation of adipose tissue suppresses the production and secretion of leptin. However, the precise nature of the neuronal populations involved in the sympathetic regulation are not completely understood. Also, it remains largely unknown how the sympathetic pathways interact with other pathways like thermo and energy-need sensory signals, that sometimes promote opposing effects to increase or decrease energy expenditure. Our previous work demonstrates that distinct leptin target sites in the hypothalamus are involved in thermo and energy need sensory signals via sympathetic adipose tissue activation to regulate energy expenditure. Yet, the necessity and sufficiency of adipose tissue sympathetic activation to control leptin levels and metabolic function has not been directly studied.

This R01 application uses the mouse as a model, and will investigate how the brain communicates with select white (WAT) and brown adipose tissue (BAT) depots via pre- and post-ganglionic sympathetic nerves to regulate leptin levels and to elucidate their interactions with thermo- and energy need sensory circuits in the hypothalamus, brainstem, preganglionic spinal cord and sympathetic ganglia in a variety of physiological conditions such as high versus low temperature and fasting versus feeding. It will identify novel excitatory and inhibitory neural circuits to these two types of adipose tissue through incorporating cutting-edge techniques proposed perhaps for the first time in this field, such as immunolabeling-enabled three-dimensional imaging of solvent-cleared organs (iDISCO) to allow impressive detailed visualization of peripheral circuits including the entire trunk of the spinal cord, and the use of stimulatory and inhibitory Designer Receptors Exclusively Activated by Designer Drugs (DREADDs) in postganglionic neurons projecting to BAT and/or WAT to assess necessity and sufficiency of these adipose tissue depots for the physiological responses to changes in ambient temperature or the nutritional status.

Public health relevance
Adipose tissue is increasingly recognized for its impact on energy expenditure, glucose and fat metabolism and is under sympathetic control. This brain-to-fat circuit has not been explored in its full extent, and specifically pre-and postganglionic neurons innervating distinct brown and white adipose tissue depots are largely unexplored. Here we propose to use the modern toolbox of neuron-specific manipulation to directly stimulate and inhibit postganglionic neurons for select adipose tissues and their interaction in metabolic control. This project is using a new brain-to-fat experimental approach that aims to integrate findings from brain circuits and adipose tissue research to generate a circuit model that is able to predict metabolic adaptations in diverse physiological states.